Readily deployable technology for reproducible cryogenic sample time-resolved electron microscopy (cryoTREM)

SUMMARY
This advanced technology grant focuses on enhancing cryogenic sample time-resolved electron microscopy
(cryoTREM) through the development of a patterned LED/LCD-based illumination system capable of capturing
multiple temporal states on a single EM grid with 4 orders of magnitude time range from 1 to 10,000 milliseconds.
This system will be developed and deployed in producing time-resolved data sets for several different biological
systems with intermediate states with varying degree of conformational magnitude. The resultant data will be
integrated with a variety of data processing methods to determine ensembles of time-resolved structures, which
can be leveraged to understand molecular mechanisms. These time-resolved EM experiments will be conducted
on multiple biological systems and processes including ligand-gated ion channels, a lipid transferase, the V-
ATPase, and synaptic vesicle fusion.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE This project combines experimental device design, fabrication and testing to provide an integrated and readily deployable system for cryogenic sample time-resolved electron microscopy (cryoTREM). Macromolecular complexes are flexible dynamic systems that undergo a myriad of structural changes in response to perturbations and the work proposed herein will produce instrumentation and reagents for capturing the structural dynamics of biological machines that can be easily deployed by cryoEM laboratories. The use of this technology by the broad community will advance our understanding of how such biological machines function, how they malfunction in disease, and will aid in the development of therapeutics for a plethora of human diseases. Furthermore, the equipment and reagents from this project will be made fully available to the research community through the establishment of a cryoTREM shared resource facility.